Investigating Extrachromosomal DNA (ecDNA) Segregation and Repair in Cancer

Project Summary
Extrachromosomal DNA (ecDNA) plays a critical role in cancer biology, contributing to tumor progression and
resistance to treatment by enabling rapid genetic adaptation through oncogene amplification. Unlike
chromosomal DNA, ecDNA exists as circular molecules that replicate independently and segregate randomly
during cell division, leading to significant genetic diversity within tumors. This unique non-Mendelian
inheritance pattern allows cancer cells to quickly adapt to environmental pressures, including therapeutic
interventions, by altering oncogene copy numbers. Recent studies have identified ecDNA across various
cancer types, where it is associated with aggressive tumor growth, increased genetic diversity, and shorter
patient survival. This collaborative project investigates the mechanisms underlying ecDNA segregation and
repair, focusing on how their circular topology affects ecDNA function and maintenance. We propose that
proper ecDNA segregation is facilitated by RNA-dependent physical tethering to mitotic chromosomes, thus
protecting against cytosolic mis-segregation and chromosomal integration (Aim 1). Using innovative genetic
tools and advanced imaging techniques, we will explore how ecDNA-encoded RNA contributes to its tethering
and segregation during mitosis. We will also explore the pathways that promote ecDNA re-integration into the
chromosome following cytosolic mis-segregation. In Aim 2, we uncover that ecDNA uniquely depends on the
mutagenic pathway of microhomology-mediated end-joining (MMEJ) for its repair, distinguishing ecDNA from
chromosomal DNA repair. We hypothesize that rampant ecDNA transcription, which leads to transcription-
replication conflicts, generates DNA lesions that create a dependency on MMEJ activity for ecDNA
maintenance. We will test the hypothesis that blocking MMEJ activity will prevent ecDNA accumulation and
block drug resistance. Last, we will design ecDNA to incorporate a palindromic sequence, facilitating its
linearization while safeguarding it from degradation (Aim 3). This will enable us to investigate the functional
importance of ecDNA circular topology, which has been proposed to allow increased transcription of
embedded oncogenes and test its impact on ecDNA segregation and repair processes. By revealing the
mechanisms behind ecDNA segregation, maintenance, and integration, we aim to discover novel therapeutic
strategies to combat drug resistance resulting from ecDNA amplification.

Public health relevance
Project Narrative Extrachromosomal DNA (ecDNA) plays a critical role in cancer by driving oncogene amplification, contributing to tumor heterogeneity, and promoting drug resistance. This collaborative proposal investigates the mechanisms behind ecDNA segregation and repair, which enable its persistence and aggressiveness in cancer cells. By targeting these processes, we highlight novel strategies to prevent ecDNA-driven resistance and improve treatment outcomes for cancer patients.